Targeting GDF15-GFRAL signaling in mitochondrial myopathies

Project Summary
Myopathy is one of the most common manifestations of mitochondrial diseases. Although genetic
and bioenergetic causes of Oxidative Phosphorylation (OxPhos) impairment are well established,
there is a limited understanding of the metabolic drivers of muscle degeneration. This knowledge
gap contributes to the lack of effective treatments for these disorders. Our recently published
studies indicate that OxPhos defective muscle initiates an integrated systemic, multiorgan
metabolic response coordinated by endocrine signals, which contributes to the pathogenesis of
mitochondrial myopathy. In the COX10 KO mouse model of mitochondrial myopathy, increasing
plasma levels of the myokine GDF15 activate central and peripheral neurocircuits through GFRAL
signaling, which over time reduce caloric intake, induce mobilization of lipid from adipose tissue,
and promote energy-consuming futile cycles in muscle. This chronic GDF15-driven fat and muscle
wasting result in a cachectic phenotype which aggravates the myopathy. Therefore, we
hypothesize that inhibiting the GDF15-GFRAL signaling with established anti-GDF15 and anti-
GFRAL antibodies will increase caloric intake, decrease lipid mobilization and attenuate energy
expenditure, thus improving body weight and muscle function. In aim 1 of this application, we will
target GDF15-GFRAL signaling to prevent cachexia in pre-symptomatic COX10 KO mice. In aim
2 we will target GDF15-GFRAL signaling to treat cachexia in symptomatic COX10 KO mice. This
study will establish if anti-GDF15-GFRAL Ab therapy improves mitochondrial myopathy and
assess whether the Ab treatment can reverse symptoms of cachexia, setting the stage for testing
anti-GDF15-GFRAL Ab therapy in human mitochondrial myopathies.

Public health relevance
Project Narrative Mitochondrial diseases are inherited metabolic disorders caused by impairment of energy production and manifest with myopathy ranging from fatigue to muscle weakness and degeneration. We have identified a muscle metabolic remodeling induced by the GDF15-GFRAL signaling pathway that contributes to the pathogenesis of mitochondrial myopathies and can be targeted therapeutically. This project focuses on the treatment of mitochondrial myopathy with antibodies to block GDF15-GFRAL signaling, prevent muscle wasting, and ameliorate myopathy.